Maintenance and Enhancement of ISO/IEC 17025 Accreditation and Whole Genome Sequencing for State Food Testing Laboratories.

Project Summary: The main objective of the Division of Laboratory Services (DLS) at the Kentucky Department for Public Health is to maintain ISO/IEC 17025 accreditation (achieved in September 2016 for food chemistry and microbiology testing) and enhance testing capabilities by expanding the scope of current accreditation for additional testing to include food microbiology whole genome sequencing analyses. ISO/IEC 17025 accreditation is one of the most important standards for testing laboratories and attests to the competency and technical capability of a laboratory to perform specific tasks. The results generated are defensible to a recognized standard. In addition, accreditation supports the traceability of technical results generated by a laboratory. In the event of a large-scale terrorist activity or other large-scale events affecting foods or food products, States and Federal authorities can use laboratory test results from accredited laboratories to respond rapidly with streamlined analytical review and enforce regulatory compliance to protect the safety of the nation's food supply. DLS is the primary servicing laboratory for conducting microbiological and chemical food analyses on behalf of the KY State manufactured food regulatory program (MFRPS) in the Department for Public Health / Food Safety Branch, which has a current food safety inspection contract with FDA and is enrolled in the MFRPS. DLS has a quality management system that is in compliance with the managerial and technical requirements of the ISO/IEC 17025:2005 standard. DLS is a Food Emergency Response Network (FERN) Laboratory and participates in Food proficiency testing and submits laboratory results through electronic laboratory exchange network (eLEXNET) as requested. The Division of Laboratory Services’s goal is to enhance laboratory activities by bringing in new testing capabilities. DLS will implement whole genome sequencing tests for environmental micro food samples to complement progressive testing performed on clinical samples in outbreak situations. This would result in faster identification of the food/pathogens implicated in the outbreak and matching clinical to environmental samples. Funding of this proposal will assist the KY State MFRPS in achieving conformance with Standard 10 “Laboratory Support” of the MFRPS and will contribute to production of accurate and reliable test data, a quicker acceptance of analytical results by FDA, and other regulatory agencies for enforcement actions, surveillance purposes and response to foodborne outbreaks. In addition, DLS will provide insight into the origin of the contaminated food by the genomic information provided by the GenomeTrackr network which will point investigators to specific food products potentially related to an outbreak. This will lead to develop a stronger international rapid surveillance system for pathogen traceback by further enhancing the GenomeTrackr network and growing the database.

Public health relevance
Project Narrative: This proposal will increase the analytical capacity for FDA through the Kentucky Division of Laboratory Services (DLS) and enhance efforts to protect the nation’s food supply. In addition, DLS will implement whole genome sequencing tests for environmental micro food samples to complement progressive testing performed on clinical samples in outbreak situations. This would result in faster identification of the food/pathogens implicated in the outbreak and matching clinical to environmental samples. In the event of nefarious-type activity or other large-scale events affecting foods or food products, States and Federal authorities can use DLS test results for rapid response and surveillance; and these response efforts will enable enforcement of regulatory compliance to protect the safety of the nation’s food supply. By funding this proposal, DLS will assist in achieving conformance with standard 10 “Laboratory Support” of the MFRPS (see-attached letter of support from Food Safety Branch/KY State MFRPS).